Yale Center for the Study of Tobacco Product Use and Addiction (YCSTP) Project 2: Addictive Threshold of Nicotine and the Impact of Sweeteners

ABSTRACT Admin Supplement: Proj 2 Addictive Threshold of Nicotine and the Impact of Sweeteners
This Administrative Supplement is a request to support an unexpected increase in costs related to Project 2.
The specific aims of this study will determine the threshold doses of nicotine for reinforcement, discrimination,
and subjective-rewarding effects individuals who smoke and whether these threshold doses change with an
inhaled sweetener (sucralose) in dependent and non-dependent smokers, as well as with an inhaled
sweetener (sucralose) delivered via e-cigarettes concurrent with IV nicotine infusions.
The project requires the use of sterile intravenous nicotine solution. Following an FDA audit, the compounding
pharmacy that supplies the nicotine solution for this project (USSF) has instituted new practices and
safeguards which have led to a significant increase in the cost of IV nicotine solution from the original quote in
included in our Project 2 budget proposal.
Project 2 depends on the availability of sterile nicotine vials that allow the administration of nicotine
intravenously. This supplement will allow us to continue this research without interruption. The findings of this
study are expected to guide the FDA in setting science-based benchmarks for reducing the risks from tobacco
products.

Public health relevance
PROJECT NARRATIVE – Project 2 (Sofuoglu) The Yale Center for the Study of Tobacco Product Use and Addiction (YCSTP) will examine how ingredients in tobacco products, including nicotine and chemicals that produce cooling and sweetness, contribute to product initiation, continued use, and addiction. Project 2 will determine if thresholds for nicotine reinforcement, discrimination, and subjective reward are altered by nicotine dependence and exposure to sweeteners.